Developing a Chemically-Controlled RAS Toolset

Project Abstract
RAS GTPase operates as a molecular switch toggling between GDP-bound (inactive) and GTP-bound forms
(active), and orchestrates dynamic cellular processes such as proliferation, migration, survival, and T-cell
development.1,2 Despite its binary nature, RAS exhibits sophisticated and dynamic signaling behavior influenced
by cellular context and subcellular localization. The lack of a precise understanding of the roles of spatiotemporal
compartmentalization in RAS hinders our understanding of fundamental signaling mechanisms and limits our
ability to develop targeted therapies for RAS-driven cancers. To address this, we will leverage a chemical genetic
tool called Chemically-Inducible Activator of RAS (CIAR) that allows the rapid and dose-dependent activation of
wild-type RAS with bio-orthogonal small molecules.8-10 Aim 1 describes efforts to use transmembrane-tethered
versions of NS3a-CIAR to dissect the impact of differential membrane localization on wild-type RAS activation
and downstream signaling. This Aim also describes the development of chemical tools for quantitatively
measuring the transmembrane localization of proteins and using a novel tool for probing RAS-GTP in its native
cellular context. Aim 2 aims to investigate the role of oligomerization of signaling proteins at membranes. An
engineered protein toolkit will be used to control the oligomeric state and study its impact on Ras-mediated
signaling. Finally, Aim 3 explores efforts to dissect how the intracellular signaling environment affects the kinetics
of magnitude of RAS activation and downstream signaling. This Aim also explores the development of a number
of chemical genetic tools for enabling intracellular protein display at membranes. Overall, the studies described
herein will offer new and important mechanistic insight into RAS signaling.

Public health relevance
Project Narrative The GTPase RAS serves as a critical molecular switch involved in cellular signaling, with mutations driving approximately 30% of human cancers. Despite persistent efforts over four decades to target RAS, once deemed undruggable, questions surrounding the spatiotemporal regulation of RAS remain. This proposal tackles these challenges by developing and applying of chemical genetic tools, protein engineering, and chemoproteomic methods to unravel how spatiotemporal compartmentalization governs RAS-driven signaling.